Machine learning Approaches to Radiological Dating of Infant Clavicle Fractures"

Project Summary
Child abuse is a major public health problem, with 8.9/1000 children abused per year (or 656,243 victims in
2019). Infants (≤1-year-old) are particularly vulnerable to abuse, and constitute 45.4% of children who die from
inflicted injuries. Most of these infants are found to have skeletal injuries at the time of death. Skeletal survey
radiographs play a pivotal role in cases of suspected infant abuse for they not only establish the presence of
fractures, they also identify fractures of different ages—a hallmark of infant abuse. In infant abuse investigations,
dating of skeletal injuries from radiographs is vital to reaching a clear timeline of traumatic events. Investigators
typically collect information to determine the presence of potential perpetrators in the victim’s environment at the
time these injuries occurred. Thus, the course of subsequent legal proceedings may depend upon the dates of
these fractures. Although clinical experience, along with the pertinent scientific literature, permit the radiologist
to draw limited conclusions from the radiographs, the task of precisely dating injuries remains challenging. In
short, there is an unmet and critical need for precise and objective dating of fractures in cases of
suspected infant abuse. In this study, we propose to develop an estimation algorithm that harnesses the power
of machine learning (ML)—a branch of artificial intelligence based on the idea of computers learning from data—
to help date infant fractures. To this end, we will compare the accuracy performance of an ML-based algorithm
to that of expert radiologists in fracture dating and will validate its clinical utility. In summary, this proposal
presents a new and provocative utilization of ML: To create and clinically validate a new radiology
decision support tool to further the ability of radiologists to date infant fractures with unprecedented
precision and accuracy. Not only will this approach enhance our ability to date individual fractures, but in the
case of multiple injuries, to determine if the fractures occurred at different times. If successful, we expect this
work will aid in reaching more accurate clinical and social assessments leading to improved case outcomes.

Public health relevance
Project Narrative The key contribution of this proposal is the development, evaluation, and validation of a machine learning (ML) technique to improve the radiologist’s ability to date infant clavicle fractures—a common, telltale sign of inflicted injury in infants. If successful in the fulfillment of aims, this work will constitute the first rigorously tested and verified application of ML to date fractures with unprecedented precision and accuracy—as well as help buttress the diagnosis of abuse by determining if fractures of different ages are present. We expect this scientific innovation will enable the radiologist to more accurately detect, diagnose and treat this prevalent, life-threatening form of infant maltreatment.